University of Washington Center of Excellence in Opioid Addiction Research

Overall Summary
The “University of Washington Center of Excellence in Opioid Addiction Research” is designed to provide
shared resources that would enhance efficiency and facilitate collaborative research for the study of the effects
of opioids on neural circuits with the goal of understanding opioid addiction mechanisms and developing novel
treatments for drug addiction. Center participants from 16 UW laboratories are using optogenetic control of
rodent behavior, in vivo neuroimaging of single cell calcium signals and other receptor signaling probes, viral
gene expression and CRISPR/cas9 manipulations to deconstruct and study opioid self-administration. This
group has a long-history of highly productive, collaborative, cutting-edge research and training that will be
strengthened by the shared resources provided by this award. The proposed Center would be comprised of
four components: The Administrative Core will coordinate resource utilization, organize monthly Research
Progress Meetings, organize training and outreach efforts. The Imaging and Neural Circuits Core would
develop shared resources for in vivo brain imaging in rats and mice using 1-Photon endoscopy, Inscopix
imaging, 2-Photon confocal microscopy, Spatial Light Modulation, fiber photometry and operant behaviors. The
Molecular Genetics Resource Core would provide DIO-AAV / CRISPR-cas9 / Canine Adeno Viral reagents,
develop new activity actuators and sensors and provide advanced training in cell-specific genetic manipulation
coupled with behavioral and computational analysis. A Pilot Project Core would enable participants and
trainees to initiate new projects utilizing the Imaging and Genetic Cores and would foster training and
collaborations within the Center laboratory groups and university community at large. The Center would
become a national neuroscience resource by providing training to visiting scientists, reagents for genetic
manipulation and novel actuators/sensors on request from investigators at other institutions. It will provide
workshops and summer courses for training advanced undergraduate and graduate students in optogenetics,
computational neuroscience, and viral design & construction techniques. All of these components would be
focused on understanding the changes in neural circuitry responsible for opioid addiction and on the
development of new therapeutic tools based on these insights.

Public health relevance
Overall Narrative Novel treatments for opioid addiction will require a better understanding of the functional changes in the neural circuitry controlling motivated behavior. Powerful new genetic and imaging tools enable high resolution visualization in rodents of neurocircuit functions that are affected by opioids. The University of Washington Center of Excellence in Opioid Addiction research will provide a set of resources through its `Molecular Genetics Resource Core' and `Imaging and Neural Circuits Core' designed to facilitate opioid addiction studies by the 16 participating research groups and to support molecular and cellular analyses of neural circuit function at the high temporal and spatial resolution necessary to advance our understanding of addicted brain function.